Development of a Companion Diagnostic Assay for Detection of ADAM8-Positive Cancers

Breast cancer (BrCa) leads to ~685,000 deaths in women yearly worldwide (WHO). While patients with Hormone
Receptor (HR) and Human Epidermal Growth Factor Receptor-2 (HER2)-driven cancers (HR+ and/or HER2+)
have benefited from endocrine and HER2-targeted therapies, they still account for the majority of deaths. The
HR and HER2 negative (HR-/HER2-) subtype, also known as Triple-negative breast cancer (TNBC), is the most
aggressive and even more challenging to treat, leading to ~25% of deaths, despite a much lower incidence.
More effective therapies are urgently needed. We identified the cell surface protein ADAM8 as an independent
marker of poor BrCa patient outcome and a driver of tumor growth and spread. Using ADAM8-positive (ADAM8+)
TNBC mouse models, we showed antibody (Ab)-based targeting of ADAM8 is an effective therapeutic (Tx)
strategy [1]. Preliminary immunohistochemistry (IHC) of primary TNBCs revealed only a subset are ADAM8+
(17/50 or 34%), suggesting a diagnostic (Dx) will be needed to identify patients who can benefit from targeted
therapy. We launched Adecto Pharmaceuticals to develop Dx and Tx products to improve the outcome of
patients with ADAM8+ cancers. ADP2, our top Tx Ab, reduces pre-existing TNBC growth and spread, improves
survival, and enhances response to standard-of-care chemotherapy. ADP2 was successfully humanized, and a
lead candidate (AD100) selected ahead of IND-enabling studies. AD100 regimens could dramatically improve
BrCa treatment. Here, we propose to develop an IHC-based Dx for ADAM8+ cancers as a companion to AD100
or a standalone prognostic for identification of patients at high risk of progressive disease. Currently, there is no
Dx for detection of these tumors. Using a panel of highly specific anti-ADAM8 monoclonal Abs (mAbs) and
Phase 1 SBIR funds, we (i) optimized IHC conditions and identified ADP2 as lead Dx Ab; (ii) developed a breast
staining/scoring control cell line microarray (CCM) with 3 lines expressing low, medium or high ADAM8, and
analyzed patient-derived xenograft samples; (iii) validated IHC assay and CCM, and established an ADAM8
scoring system, in primary BrCa samples (which completed all proposed aims). Consistent with earlier findings,
ADP2 IHC showed 36.1% of TNBCs (22/61) were ADAM8+, and unexpectedly 32.8% of non-TNBC BrCas
(115/351). A 10-year age-adjusted analysis of the HR+/HER2- subtype, with largest sample size, revealed
ADAM8 score associated with poor survival, providing early support for a prognostic use of this assay. In this
Direct to Phase 2 application, we propose to: 1) refine the ADP2 assay to permit accurate characterization of
ADAM8 in any BrCa sample within ASCO/CAP guidelines; 2) verify ADAM8 positivity rates and study the
prognostic value of the assay in BrCa; 3) test the predictive value of the assay for AD100 response using TNBC
and HR+/HER2- mouse models; 4) complete CLIA validation of the assay by a clinical Dx contractor. Successful
completion of the proposed aims will result in an ADAM8 IHC assay with CLIA standard operating protocols
ready for testing in future clinical trials.

Public health relevance
The ADAM8 cell surface protein is an independent prognostic indicator of poor breast cancer (BrCa) patient outcome, present in multiple BrCa subtypes and identified as a target for treatment. An ADAM8 immunohistochemistry (IHC)-based assay can i) identify patients for treatment with a novel ADAM8 antagonist antibody-based therapy, in development by Adecto, and ii) indicate prognosis, and thus direct treatment strategies with existing standard-of-care therapies to enhance survival of patients with BrCa that expresses ADAM8. Here, we propose to develop a CLIA-validated ADAM8 diagnostic IHC assay ready to enter clinical testing.